Elucidating sympathetic vasoconstrictor mechanisms of autonomic dysreflexia in persons with spinal cord injury

Autonomic dysreflexia (AD) is a potentially life-threatening consequence of cervical and high thoracic (above
T6) spinal cord injury (SCI) characterized by abruptly high elevations in blood pressure in response to noxious
stimuli below the injury level. 1,2 In addition to the potential morbidity caused by acute rise in blood pressure,
recurrent AD over a longer period has been associated with changes in vascular structure that lead to CVD
3,4and impaired immune function, 5 which are both leading causes of mortality in persons with SCI. 6 While
peripheral arteriolar vasoconstriction (VC) is documented to be pronounced during AD,7,8 The
pathophysiological mechanisms of this VC are not well defined. A few proposed mechanisms include: 1)
increase in neuronal release of norepinephrine (NE) and co-transmitters (CT); 2) post-junctional alpha-receptor
hypersensitivity; 3) impaired reuptake of NE and/or 4) increases in circulating catecholamines (Epinephrine >
NE) from adrenal stimulation.2,9 None of these mechanisms has been fully proven or is widely accepted.
Furthermore, there are no known effective preventative or targeted treatment of the underlying
pathophysiology of the AD, as the mechanisms are unknown. Current clinical care of AD with pharmacologic
therapies is not without potential for significant side effects. Pharmacologic treatment includes short acting anti-
hypertensives (e.g.; nitroglycerin and nifedipine), which can cause systemic hypotension. There is no known
treatment targeting the underlying arteriolar vasoconstriction mechanisms of AD since they are unknown.
Elucidating the underlying pathophysiology will facilitate the development of targeted treatment(s) to attenuate
AD without significant adverse side effects. Our proposal aims to take the next step in elucidating the
underlying pathophysiology of VC during AD. We aim to test one of the proposed mechanisms using a novel
non-invasive technique never before used in studies testing VC pathology during AD. Specifically we will test
following hypotheses: 1) Blockade of pre-synaptic neural release of NE and CT will abolish cutaneous VC
during AD and 2) blockade of post synaptic alpha adrenergic receptors will decrease but not fully abolish VC
during AD. Arterioles of the skin are easily accessible to test these hypotheses. We will use a novel and non-
invasive technique of local iontophoretic delivery of pharmacologic agents combined with skin blood flow
monitoring by laser Doppler flowmetry (LDF) and mean blood pressure (MAP) monitoring to define the
underlying pathophysiology.10 Specific AIM 1 will compare the impact of a sympathetic neuronal blocking
agent (bretylium = BT; blocks release of NE and co-transmitters from sympathetic noradrenergic nerves)) on
cutaneous vascular conductance (CVC=LDF/MAP) during an AD episode at BT treated and control (CON)
sites on a forearm and posterior calf. CVC will be compared at baseline = BL at normotension then every 20
seconds during AD stimulated by bladder percussion. If the increased arteriolar vasoconstriction is due to
increased neuronal release of NE and CT then the sites treated with BT will demonstrate comparatively less
vasoconstriction. Specific AIM 2 will evaluate the impact of non-selective alpha-adrenergic receptor blockade
(phentolamine – PT) on CVC during AD. Before using PT during AD, the optimal PT dose to block alpha
receptors will be determined by utilizing alpha 1 and 2 agonists with PT. After the PT dose required for total
alpha –adrenergic blockade is determined, similar to AIM 1, CVC will be measured at PT treated and adjacent
untreated CON sites. If the increased arteriolar vasoconstriction is due to NE release, then the CVC changes
of PT and CON sites will differ.
Ultimately, elucidating this information will 1) guide treatment, and potentially prophylaxis, to better target the
underlying pathophysiology of VC during AD, with less systemic side effects and 2) help prevent the vascular
adaptations with potential to contribute to CVD and impaired immunity associated with recurrent AD that both
may increase mortality.

Public health relevance
Autonomic dysreflexia (AD) occurs in persons with spinal cord injury when an unpleasant stimulus causes a sudden rise in blood pressure to potentially life threatening levels. Not only can the sudden rise be life- threatening, but recurrent AD has been associated with changes in blood vessel structure that can lead to cardiovascular disease and impaired ability to fight infections, which can both increase risk of death in the long term. The underlying cause of the rise in blood pressure is not fully understood, so determining optimal prevention and treatment methods is problematic. This project will test two potential mechanisms of this blood pressure rise in the skin of persons with spinal cord injury during AD to guide prevention and treatment of this life threatening condition.